Strengthening Clinical Support for Providers Working with Women Living with HIV to Manage Menopause

The proposed K01 Award will provide the candidate, Dr. Lauren Suchman, with 1 training and skills to achieve
her long-term goal of becoming an independent investigator who enhances access to quality sexual and
reproductive health (SRH) care across the lifespan. Dr. Suchman is an Assistant Professor at the University of
California San Francisco (UCSF) with expertise in women’s health, SRH, and HIV with a strong foundation in
qualitative methods. The tailored training and research programs described in this K01 application will enhance
Dr. Suchman’s ability to conduct independent research in line with NIH’s new high-priority area outlined in
NOT-OD-24-119: Research Opportunities Centering the Health of Women Across the HIV Research
Continuum. She requires additional training to: 1) develop topical expertise in HIV and menopause with a focus
on symptom management and its impact on health outcomes; 2) develop proficiency in clinical research and
statistical methods; 3) obtain experience in participatory intervention design; and 4) develop professional skills
for career advancement. She has assembled a mentorship team of experts in HIV and menopause, the
epidemiology of brain health outcomes in aging women with HIV (WWH), biostatistical methods, and
participatory intervention design. These mentors will support Dr. Suchman’s transition to independence
through didactic coursework, one-on-one meetings and tutorials, access to adjacent research teams and
working groups, and completion of an independent research project. Dr. Suchman’s program of research
centers on the midlife health of WWH in the U.S. with a particular focus on the San Francisco Bay Area.
Menopause is a critical inflection point in the health of midlife cisgender women, which disproportionately
impacts WWH. The menopausal transition and severity of associated symptoms has also been associated with
suboptimal engagement in HIV care and antiretroviral treatment. However, WWH are less likely to be offered
efficacious treatments for menopausal symptoms and less likely to accept these treatments if offered
compared to women without HIV. To address these gaps, the study for this K01 aims to understand how
menopausal phase and symptom severity affect HIV outcomes in midlife WWH and determine how therapeutic
management of menopausal symptoms can best be implemented in an HIV clinic. Study outcomes will serve
as proof of concept for an R01 proposal to develop and empirically test a multi-level intervention for both
providers and patients. Research and training will occur at UCSF and will leverage the Multicenter AIDS
Cohort Study (MACS)/Women's Interagency HIV Study (WIHS) Combined Cohort Study (MWCCS) and the
UCSF Women’s HIV Program. Research findings and skills obtained through this K01 award will facilitate Dr.
Suchman’s transition to become an independent investigator who develops interventions aimed at improving
SRH care for WWH as they age.

Public health relevance
Project Narrative Although symptoms associated with the menopausal transition (MT) disproportionately affect cisgender women with HIV (WWH) and impact adherence to antiretroviral treatment, the MT is under-researched among WWH and HIV care providers have few tools to support their patients going through this transition. The proposed study aims to examine the relationship of menopausal phase and symptom severity with HIV care and treatment outcomes, and develop and pilot test an intervention to consistently implement menopause treatment support for midlife WWH in a clinical setting. Findings will support the development of a multi-level menopause support intervention for both HIV care providers and their patients to be empirically tested in an R01.